Metabolomics Core

PROJECT SUMMARY/ABSTRACT – Metabolomics Core
The goals of the Metabolomics Core (MC) remain to advance the understanding of metabolism and metabolic
flux in relation to iron, heme, hematopoeisis and red cell biology through the use of cutting edge technology,
newly developed methodologies and Bioinformatic analyses. The need for the MC continues to expand as the
applicability of this technology to model systems is further realized. Our MC core, which has been in existence
for over 15 years, has rapidly evolved to meet user demand including the development of extensive education
(workshops), which are made available to all users through the CIHD Enrichment activities, high throughput
sample processing, improve flux analysis and utilization of bioinformatic tools to process data and interpret
results. We have increased personnel focused on metabolomics, lipidomics and bioinformatics as well as
adding cutting edge instrumentation (e.g. high resolution orbitrap instrument) to satisfy the demand for high
end isotope tracer and flux analysis. The Core will continue to refine its methodologies, standardize reporting
using developed custom data analysis reporting software and provide educational opportunities for successful
investigator-initiated research and advancement.